Development and Proof-of-Concept Implementation of the South Florida Miami RADx-rad SARS-CoV-2 Wastewater-Based Surveillance Infrastructure

PROJECT SUMMARY
The University of Miami (UM), with three primary campuses in Miami, Florida, is geographically spread within
one of the worst current COVID-19 hotbeds. UM has deployed an elaborate human surveillance testing, tracking
and tracing (3T) system to monitor the student body, faculty, and staff. This 3T system includes a major hospital
that is part of UM and that treats COVID-19 patients. To augment this COVID-19 monitoring system, UM has
deployed a pilot wastewater surveillance program for detecting SARS-CoV-2 from clusters of buildings on
campus. Weill Cornell Medicine (WCM) is located in New York City, NY, an area that until recently had one of
the worst outbreaks of COVID-19. WCM has established an international consortium for SARS-CoV-2
environmental surveillance, including in NYC and globally with the MetaSUB Consortium, which is creating
metagenomic and metatranscriptomic maps of the world’s sewage. Based on this work at both UM and WCM,
this proposal aims to develop, implement, and demonstrate effective and predictive wastewater surveillance by
optimizing sampling, concentration, and detection strategies. Working closely with the RADx-rad Data
Coordination Center (DCC), this application (SF-RAD) will develop and implement data standards and
informatics infrastructure and perform integrative analyses to make all data, results, and models available to the
community, thus providing a critical contribution to the national SARS-COV-2 RADx-rad Wastewater Detection
Consortium. Our objectives will be addressed through three aims. Aim 1: Data Standardization, focuses on
developing and implementing data standards and quality metrics, and establishing the operational infrastructure
to manage SARS-CoV-2 wastewater-based surveillance datasets and metadata. Aim 2: Wastewater
Characterization, focuses on optimizing wastewater surveillance protocols and parameters for wastewater
sampling, sample concentration, and viral detection technologies. Aim 3: Integration with Human Health
Surveillance, focuses on metatranscriptomic analyses and on the integration of wastewater quantification data
with community and hospital COVID-19 prevalence, to develop predictive models to detect local and community
level spread of COVID-19. All data will be made Findable, Accessible, Interoperable and Reusable (FAIR) in
close collaboration with the DCC, and will be collected and managed with attention to ethical issues in
surveillance and data management, including efforts to ensure research rigor and reproducibility. The results
from this proposal will develop and deploy experimental and informatics infrastructure and operations as part of
the national RADx-rad SARS-CoV-2 wastewater surveillance network and will provide a proof-of-concept
implementation to use wastewater for infectious disease surveillance for early detection of localized COVID-19
outbreaks.

Public health relevance
PROJECT NARRATIVE Through this collaborative study between the University of Miami in Florida and Weill Cornell Medicine in New York, we will generate, standardize, integrate, compare and make available to the RADx-rad Data Coordination Center (DCC), SARS-CoV-2 human surveillance and wastewater quantification data with various sampling, processing, detection, and analysis approaches. We hypothesize that sensitivity (enhanced detection and recovery) can be improved by optimizing sampling and concentration strategies, and that specificity (viral strain identification for epidemiologic tracking) can be improved by optimizing wastewater detection methods. The results from this proposal will develop and deploy experimental and informatics infrastructure and operations, provide a proof-of-concept implementation to use wastewater for infectious disease surveillance, and advance work towards a model capable of predicting local and community level spread of COVID-19 and emerging pathogens based upon measurements of SARS-CoV-2 and other viruses from wastewater.